Virulent Rickettsia species utilize the CD300f phosphatidylserine-binding receptor on macrophages for host colonization and pathogenesis

PROJECT SUMMARY
Rickettsia species are arthropod-borne obligate intracellular bacteria with both symbiotic and pathogenic
lifecycles. The global impact of rickettsial infections is highlighted by the resurgence of human infections with R.
rickettsii (etiologic agent of Rocky Mountain Spotted Fever) in Central and South America, reappearance of R.
conorii (etiologic agent of Boutonneuse Fever) in Europe, Middle East, and Africa9 and the recent outbreaks of
R. rickettsii and R. typhi (etiologic agent of murine typhus) in the USA. Unfortunately, our inadequate
understanding of Rickettsia-host interaction, in particular at the level on rickettsial engulfment via receptor-ligand-
mediated phagocytosis on professional host defense cells, like macrophages (MΦ), has significantly impaired
the development of effective therapeutics against these pathogens. To address these knowledge gaps, we
propose to: i) characterize the specific rickettsial outer membrane glycerophospholipid ligand(s) involved in the
phagocytic process of SFG and TG rickettsiae by MΦ, ii) decipher the role of efferocytic receptor, CD300f, in
facilitating host colonization of virulent Rickettsia species. Our preliminary work identified phosphatidylserine
(PS), a well-characterized “eat-me” signal involved in the phagocytosis of apoptotic cells (aka efferocytosis), as
a putative ligand on outer membrane of rickettsiae. We further validated PS as crucial ligand for engulfment of
R. typhi and R. rickettsii [Shelia Smith], two virulent bacteria representing the TG and SFG, respectively, by using
recombinant Annexin V, a molecule known to block PS-mediated efferocytosis, in bone marrow-derived
macrophages (BMMΦ). As PS-dependent phagocytosis requires PS-receptor recognition, we focused on
CD300f, a type I transmembrane cell surface receptors with a high binding affinity to PS. Using WT and CD300f-
/- BMMΦ, we showed that engulfment of R. typhi and R. rickettsii was dependent on CD300f expression, which
was further confirmed by αCD300f antibody-mediated neutralization assays on WT BMMΦ. We tested the role
of CD300f in vivo, by establishing mouse models of rickettsiosis with ~LD50 for both R. typhi and R. rickettsii
species in C57BL/6J WT mice and showed that, unlike WT mice, CD300f-/- animals were protected against
Rickettsia-induced lethality. Furthermore, in vivo depletion of MΦ, via clodronate-liposomes, suggest that
CD300f-expression on MΦ contributed to the protection against Rickettsia-induced lethality. Hence, we will test
the hypothesis, that both SFG and TGs Rickettsia exploit efferocytic signaling to invade MΦ, using the following
Aims: to identify rickettsial outer membrane glycerophospholipid [phosphatidylserine (PS) or other] ligand(s)
involved in the engulfment and colonization of pathogenic Rickettsia by MΦ (Aim 1) and define the contributing
role of glycerophospholipid-binding receptor, CD300f, in promoting engulfment and colonization of the host by
pathogenic Rickettsia in MΦ (Aim 2). Under this “Exploratory/Developmental Research Grant Program” we will
study the mechanisms by which rickettsiae from both SFG and TG exploit the normally efferocytic CD300f-ligand
systems on MΦ to successfully colonize the host. In sum, the purpose of this grant is to unveil mechanisms of
rickettsial invasion with the goal to identify more proficient targets for anti-virulence therapy.

Public health relevance
PROJECT NARRATIVE Arthropod-borne Rickettsia species are highly diverged with both symbiotic and pathogenic lifecycles. Some Rickettsia species are notoriously pathogenic and associated with high morbidity and mortality in humans. However, the field of Rickettsia-host interactions remains poorly understood, which in turn has negatively impacted the development of effective therapeutics or a vaccine against these increasingly recognized rickettsioses. Here, we will investigate the importance of phosphatidylserine-recognizing receptor, CD300f, in facilitating host dissemination of highly pathogenic Rickettsia species from both spotted fever and typhus groups. In addition, we will study the mechanism by which Rickettsia species exploit this ligand(s)-receptor system of efferocytosis to invade macrophages. This proposal aims to unveil mechanisms of rickettsial invasion with the goal to identify a novel link that can be exploited for an anti-virulence strategy.